Type 1-2 immune cross-regulation in the lung

Project Summary
Respiratory viral infections are a prevalent and ongoing threat to global health, as evidenced by seasonal
Influenza A infections and the SARS-CoV-2 pandemic. Notably, the association between allergy and asthma
and the severity of respiratory viral illness has been long observed but poorly understood. Group 2 innate
lymphoid cells (ILC2s) and the adaptive counterpart Type 2 CD4 helper cells (Th2) have been extensively
investigated for their role in allergic inflammation. Our group has described the localization of these type 2
lymphocytes (T2L) in non-lymphoid tissues, such as the lung, at rest and under allergic and mixed type 1-2
inflammation, observing localization near large airways and vessels at rest and expansion to the tissue
parenchyma with allergic inflammation. Interestingly, in mixed type 1-2 inflammation, T2L parenchymal
distribution is restricted due to Interferon gamma (IFNγ) signaling on T2L. My preliminary data demonstrates that
IFNγ-mediated restriction also occurs following viral respiratory infection with Influenza A virus (IAV, PR8) and
impacts mouse body weight and lung function. In parallel, I have demonstrated that loss IFNα/β signaling on
T2Ls increases body weight loss and impairs lung function in IAV, potentially through a distinct mechanism.
These data suggest that IFN-mediated restriction of T2L and T2L topography is critical for appropriate viral
clearance and/or tissue repair in viral respiratory infection. Mechanisms of IFN-mediated restriction of T2L have
been explored by many groups, including ours, however how this restriction of topography and counter-regulation
of T1 immunity by T2L dictate the immune response to viral infection remains elusive. I hypothesize that IFN
signaling regulates the topography and function of lung T2Ls in pulmonary viral infections. This proposal will
define the topography of T1-T2 cross-regulation in the setting of pulmonary viral infection (Aim 1) and evaluate
mechanism of interferon mediated restriction of type 2 lymphocytes (Aim 2). Completion of these aims will
elucidate the role of canonical type 1 and type 2 cytokines in mediating tissue resident lymphocyte function in
complex inflammation, providing novel mechanistic insight into how topography dictates immunity. Completion
of this study provides a foundation for the development of precision therapeutics to selectively regulate lung
resident lymphocytes subsets to impact the outcome of diverse lung diseases.

Public health relevance
Project Narrative Pulmonary viral infections and inflammation are leading causes of morbidity and mortality worldwide. A coordinated multi-immunity arm approach is critical to respond to damage and infection, and also to resolve inflammation and repair tissue. The cellular interactions between Type 1 lymphocytes (T1L) and Type 2 lymphocytes (T2L) and dynamic cross-regulation between T1L and T2L that comprise lung resident immune system are poorly understood. This work will investigate the cross-regulation of type 1 and type 2 immune responses in pulmonary viral infection, which would inform the design of new precision therapeutics to ameliorate pulmonary inflammation in humans.